ACTG 343--PROTECTIVE RANSOMIZED DOUBLE BLIND THREE MAINTENANCE REGIMENS

Compare the sustained suppression of plasma HIV RNA among three treatment regimens containing combinations of ZDV, 3TC and IDV after 24 weeks induction therapy with ZDV/3TC/IDV.